Long-Term Approaches to Treating Osteoporosis

Project Summary/Abstract
Osteoporosis, a skeletal disease characterized by compromised bone strength and increased risk of fracture,
affects 10 million older adults in the United States. Approximately 50% of postmenopausal women and 25% of
white men over age 60 will experience an osteoporotic fracture in their lifetimes, and the morbidity, mortality,
and costs are high and projected to increase with the aging of the U.S. population. There are many effective
pharmacological treatment options for osteoporosis, which broadly fall into categories of antiresorptive agents
that inhibit bone breakdown and anabolic agents that build bone. However, individual osteoporosis
therapies are not recommended for indefinite use, although osteoporosis is a chronic disease that
requires long-term management to maintain reduced risk of fragility fracture. Thus, treatment of
osteoporosis over the lifetime involves transitions between agents. Sequential use of osteoporosis
medications is a novel and important area of investigation that requires further examination. Additionally, the
use of combination treatment regimens with multiple medications is another important topic of interest that may
be effective and appropriate short-term therapy for some individuals with osteoporosis at particularly high
fracture risk. Currently, there is little scientific evidence to guide physicians and patients with
osteoporosis on best strategies for transitions between medications for long-term treatment, and this
has been identified as a key knowledge gap in the field by professional societies and the NIH. With the
work proposed in this application we aim to address this knowledge gap by evaluating many different long-term
treatment strategies for osteoporosis, including sequential and combination therapies, to identify the best
therapeutic approaches over the lifetime. To do so, we propose to first perform meta-analyses of clinical
studies on the efficacy of sequential and combination therapies for osteoporosis (Aim 1). Subsequently, we will
perform comprehensive cost-effectiveness analyses comparing various long-term treatment strategies,
including sequential and combination therapy regimens, as well as the use of single therapeutic agents with
intermittent drug holidays, exercise therapy, and usual care (calcium and vitamin D only) for patients with
osteoporosis and different clinical characteristics (Aim 2). Our research findings will elucidate which
osteoporosis treatment strategies are most effective and cost-effective for individuals with various clinical
characteristics over the lifetime, and thus directly address one of the biggest challenges facing physicians who
treat patients with osteoporosis. This innovative investigation will help provide the framework for evidence-
based and individualized management of transitions of therapy for millions of Americans with osteoporosis.

Public health relevance
Project Narrative Osteoporosis affects 10 million older Americans, and is associated with significant morbidity, mortality, and costs. Although there are many effective osteoporosis treatment options, no single therapy is recommended for indefinite use and thus long-term management of osteoporosis involves transitions between agents. Optimal approaches to long-term osteoporosis treatment, including how best to manage sequential and possibly combination use of different types of medications over a patient’s lifetime, are unknown and a major knowledge gap in the field. With the work described in this proposal, we aim to provide evidence to guide treatment decisions over the lifetime for patients with osteoporosis. To do so, we propose to first perform meta-analyses of clinical studies on the efficacy of sequential and combination osteoporosis treatment strategies; and then carry out comprehensive cost-effectiveness analyses to compare the effectiveness and cost-effectiveness of a variety of long-term treatment strategies for patients with osteoporosis with different clinical characteristics.